Systems Analysis of Healthcare-Associated Infection Prevention during the COVID-19 Pandemic

Background: Effective healthcare-associated infection (HAI) prevention requires multiple complex interventions
(e.g., hand hygiene, environmental cleaning, personal protective equipment use, and evidence-based patient
procedure protocols such as central line maintenance). The COVID-19 pandemic’s effects on healthcare (e.g.,
staffing shortages, supply chain disruptions, modified protocols to reduce exposure) also impacted HAI
prevention. Retrospective analyses have found differential impacts on HAI rates during the pandemic, with
some HAIs increasing and others decreasing. However, there has not yet been an assessment of how the
COVID-19 pandemic specifically impacted guideline-concordant HAI prevention practices.
Significance: This pilot project directly addresses HSR&D’s research priority to enhance the Quality and
Safety of Health Care by gathering critical information regarding the implementation of HAI prevention
practices during the COVID-19 pandemic. Information gathered here will inform the effective implementation of
HAI prevention activities, including resuming guideline-concordant HAI prevention practices, to reduce HAIs
across VA and increase the quality and safety of the healthcare received by Veterans.
Innovation and Impact: We will conduct a work systems analysis using the Systems Engineering Initiative for
Patient Safety (SEIPS) framework, which allows for the assessment of barriers and facilitators within and
between each individual work system element (people, tools and technology, task, organization, and
environment). This granular analysis allows for identifying and addressing specific barriers to implementation,
which can be difficult to identify in complex work systems like those in HAI prevention. By addressing these
barriers, we can develop implementation strategies to support the resuming of guideline-concordant HAI
prevention practices in work systems that were or are continuing to be affected by COVID-19-related impacts.
Specific Aims: In this pilot project, we aim to:
1. Conduct a work systems analysis of HAI prevention during the COVID-19 pandemic among acute
inpatient care facilities in VISN12 to identify specific impacts of the pandemic on HAI prevention and
HCW-reported needs for improved HAI prevention during the pandemic.
2. Identify barriers and facilitators to resuming IPC best practices in the COVID endemic era.
Methodology: We will conduct semi-structured interviews with 1) 1-2 HAI prevention stakeholders and 2) up to
5 frontline nursing personnel at each of the 8 VA medical centers in VISN12. We will use interview guides
structured around the CDC’s multidrug-resistant organism prevention strategies and the SEIPS framework to
probe pandemic-related changes to HAI prevention practices as well as reasons behind these changes and
barriers to resuming practices. We will use a rapid qualitative inquiry approach to analyze interview data,
ultimately producing 1) a specific list of HAI prevention practices that were substantially modified during the
COVID-19 pandemic and require additional implementation support to resuming practices; 2) work system
element barriers and facilitators to conducting these practices during the pandemic; and 3) a logic model
guiding the development of a larger research project on priority HAI prevention practices.
Next Steps/Implementation: This pilot project will identify specific HAI prevention practices requiring additional
implementation support, leading directly to a larger research project to gather VA-wide data on the
implementation of these practices. We will also then develop and test implementation strategies to maximize
effectiveness of the practice in reducing HAIs while minimizing burden on healthcare workers. This work will
thus improve VA’s ability to respond to major disruptions to resources and processes (as COVID-19 was) while
maintaining the safety and quality of care for Veterans.

Public health relevance
Effective healthcare-associated infection (HAI) prevention requires multiple complex interventions across the work system. The COVID-19 pandemic also broadly impacted HAI prevention, and increases in some HAI rates have been observed during the pandemic. There is now an urgent need to assess how the implementation of HAI prevention practices was impacted in order to 1) develop strategies to support the resumption of effective practices and 2) identify practices needing future analysis to develop implementation strategies that will maximize effectiveness while minimizing provider burden. In this pilot project, we will analyze the effects of the COVID-19 pandemic on HAI prevention through all work system elements (people, tasks, tools, environment, and organization). This analysis will identify practices interrupted during the pandemic with barriers and facilitators to resuming these practices. We will also use these findings to create a model for future, larger-scale implementation studies into HAI prevention during resource-constrained settings.